Mechanisms of venous thrombosis and renal dysfunction in sickle trait

Worldwide, there are an estimated 300 million individuals who are carriers of the sickle cell β-globin gene (a
condition known as ‘sickle cell trait’ (SCT)). While generally regarded as a benign condition, SCT has been
shown to be associated with venous thrombosis and chronic kidney disease. We propose that harsh biophysical
conditions within venous thrombi or in the inner renal medulla induce sickling of SCT red blood cells (RBCs) that
promotes activation of coagulation and reduced RBC deformability while increasing RBC adhesiveness. To test
this hypothesis, we will use both human SCT blood samples as well as heterozygous (AS) Townes sickle cell
mice to study the RBC-dependent mechanisms that lead to venous thrombosis and chronic kidney disease. We
have established that AS mice develop larger experimental venous thrombi than control animals. Additionally,
like their human counterparts, AS mice manifest early onset glomerular hyperfiltration and albuminuria with age-
dependent reduction in glomerular filtration rate. Sub-contracts with the University of Alabama at Birmingham
and Johns Hopkins University will augment the recruitment of human subjects with SCT at UNC Chapel Hill.
Blood from all subjects will be analyzed in the UNC Blood Research Center using a panel of laboratory assays
that mimic the biophysical environments encountered by RBCs in the kidney or within newly formed blood clots.
The mouse model studies will be used to test the ability of anti-sickling, anti-thrombotic and anti-adhesive
therapies to prevent/reduce enhanced venous thrombosis and renal dysfunction observed in the AS mice.

Public health relevance
Epidemiologic studies have demonstrated that sickle cell trait (SCT) is associated with both venous thrombosis and chronic renal injury. We propose that unique biophysical conditions within venous clots and within the inner renal medulla promote sickling in sickle trait erythrocytes that can result in an increased tendency to blood clotting and kidney dysfunction. Our project will examine this hypothesis in human samples and a mouse model in order to identify the best therapeutic approach to attenuate these complications.